Human induced pluripotent stem cell-derived models of SLC6A1-related epileptic encephalopathy

PROJECT SUMMARY/ABSTRACT
Myoclonic Atonic Epilepsy (MAE), a rare developmental and epileptic encephalopathy (DEE) characterized by
frequent severe seizures, developmental delay, and intellectual disability, has been linked to loss of function
variants in the SLC6A1 gene. The SLC6A1 gene encodes the γ-aminobutyric acid (GABA) transporter 1 (GAT-
1), the most abundant GABA transporter in the brain which is responsible for the reuptake of GABA at the
synapse. In humans and rodents, SLC6A1 DEE variants result in reduced GABA uptake and lead to
physiological, behavioral, cognitive, and developmental abnormalities including neural network hyperexcitability
and epilepsy. However, the mechanisms by which GAT-1 haploinsufficiency (HI) results in epilepsy remain
unclear. An in vitro human model of SLC6A1 HI is therefore critical to elucidate disease mechanisms and test
potential therapeutics. The objective of this project is to use our newly developed 2-D and 3-D human induced
pluripotent stem cell (iPSC)-derived in vitro models of SLC6A1 HI to explore alterations in GABAergic
signaling, early cortical development and neuronal excitability. We hypothesize that SLC6A1 HI alters brain
development and GABAergic signaling leading to neuronal network hyperexcitability in MAE patients.
This hypothesis is based in part on our unexpected finding of severe interneuron migration defects in SLC6A1
heterozygous and homozygous CRISPR knockout and patient ganglionic eminence-like organoids. Novel
methods, including a new 3-D medial ganglionic eminence-like organoid model which I have developed and
transcription factor-induced GABAergic neurons (iGNs) derived from CRISPR gene edited iPSCs will be used
to test this hypothesis. I will assess neuronal morphology, gene and protein expression, neural progenitor
proliferation/differentiation/migration, interneuron maturation and GABAergic synaptogenesis to evaluate the
developmental consequences of SLC6A1 HI. Functional assays, including whole-cell patch-clamp recordings,
calcium imaging, multielectrode array recordings, and local field potential recordings, will be conducted to
examine electrophysiological activity at single-cell and network resolutions, while GAT-1 transport activity will
be measured using a tritiated GABA uptake assay. Based on our preliminary data and previous work, a 50% or
greater reduction in GAT1 expression and function is anticipated in patient and het/homozygous CRISPR
knockout lines, as well as delayed migration of SLC6A1 HI and knockout cells compared to controls. Deficits in
GABAergic neuron maturation, synaptogenesis, and network formation are also expected. The results of this
study will yield significant insight into SLC6A1-related DEE mechanisms and will provide the broader scientific
community with a platform to study a wide range of genetic epilepsies and to test future therapeutic targets.
The proposed experiments, mentoring team and training plan will provide me with the necessary growth and
development as a scientist to become a successful independent investigator.

Public health relevance
Project Narrative Myoclonic Atonic Epilepsy is a severe neurological disorder that has been linked to loss of function mutations in the SLC6A1 gene. Reduced SLC6A1 expression and function leads to altered signals from inhibitory brain cells and results in developmental abnormalities and epilepsy, yet the role that SLC6A1 plays in the development of inhibitory brain cells and the resultant epilepsy remains unknown. We anticipate that these studies will contribute considerable knowledge to the epilepsy and neurodevelopmental fields, and lead to novel treatment strategies for individuals with severe childhood genetic epilepsies caused by mutations in SLC6A1 and related epilepsy genes.